Small molecules combination therapy using polypharmacology approach as a novel treatment paradigm for rare bone disease

There is a critical need to improve drug development strategies for rare diseases, as more than
7000 rare and neglected diseases currently have no treatments available. At the same time, as
new drug therapies remain costly and time-consuming, repositioning existing drugs and drug
candidates offers an alternative approach to developing therapeutics for rare diseases.
Nostopharma seeks to address this need by developing repurposed drug combinations as a
promising approach to achieve a synergistic therapeutic effect, dose, and toxicity reduction. Our
Phase I objectives are to demonstrate the feasibility of repurposing a small molecule combination
therapy, formulated in a proprietary way, to treat a rare genetic disease- Progressive osseous
heteroplasia (POH). POH is a rare disease with no effective drug-based therapy, where bone
tissue forms in the extraskeletal soft tissue in response to inactivating mutations in the GNAS (the
stimulatory alpha subunit of a guanine nucleotide-binding protein) gene locus. Hedgehog
signaling (Hh) has a seminal role in mesenchymal progenitor fate choice and inappropriate
differentiation into osteoblasts and ectopic bone formation in soft tissues. Nostopharma will
demonstrate the feasibility towards altering the aberrant mesenchymal progenitor cells
differentiation utilizing combinations of Hedgehog pathway inhibitors. Our approach
simultaneously targets the distinctive components of the Hh pathway to allow synergetic inhibition,
which can significantly reduce effective doses and potential side effects and overcome the drug
resistance factor that frequently hinders the success of monotherapies. This proof of concept will
involve phenotypic screening of drug combinations and in-vivo efficacy in the POH mouse model.

Public health relevance
Project Narrative Progressive osseous heteroplasia (POH), an extremely rare genetic disorder, with currently no effective treatment available, is characterized by abnormal and progressive development of bone in areas of the body where bone is not normally present (heterotopic ossification). Nostopharma is developing repurposed drug combinations as a promising approach to achieve a synergistic therapeutic effect, dose, and toxicity reduction of Hedgehog pathway (Hh) inhibitors for POH patients. The study will evaluate the synergistic activities of three small molecules towards altering the aberrant mesenchymal progenitor cells differentiation into bone cells and drug combination efficacy in a clinically relevant mouse model of POH.